PREMAP - Predictors and Risk Evaluation for Menopause-Associated Psychosis

Schizophrenia and other psychotic disorders are typically thought of as disorders of adolescence and early
adulthood: the peak incidence of new psychotic disorder diagnoses is from 15 to 19 in men and 20 to 24 in
women. However, women also demonstrate a second peak of incidence and vulnerability to the illness in their
40s and early 50s. Theories have been proposed to explain this second peak, including appeals to the
neuroprotective effects of estrogen and other reproductive hormones, which wane in the years preceding
menopause. Despite these observations and theoretical groundwork, very little evidence exists to identify risk
factors for development of psychosis in women experiencing the menopause transition. This is partly because
development of psychosis in this population is relatively rare and is thus difficult to observe. In response to
the NIMH funding opportunity announcement entitled, “Mood and Psychosis Symptoms during the
Menopause Transition”, we propose a two-pronged approach to identify risk factors for development
of psychosis during the menopause transition. In our first aim, we propose to recruit from established local
and national sources 179 individuals who have developed a first episode of psychosis during the menopause
transition and to retrospectively identify elements of medical, reproductive, psychiatric, and family history that
predispose to the development of psychosis when compared to 144 matched controls who developed
depression in the same period. We hypothesize that women who developed psychosis during the menopause
transition will report a prodromal period of attenuated symptoms preceding the development of frank
psychosis, that factors generally predisposing to psychosis onset will be relatively over-represented in the
psychosis cohort, and that psychiatric disorders tied to hormone fluctuations will be elevated in both cohorts
relative to population rates. In our second aim, we propose to leverage our team’s established expertise in
identifying risk factors for psychosis to prospectively study women who have attenuated psychotic symptoms,
elevating their risk for developing psychosis. From established sources, we will identify 196 women who are at
clinical high risk for psychosis during the earliest phases of the menopause transition. We will then follow these
women and 98 matched healthy controls over 2 years, collecting clinical, behavioral, computational,
endocrinological, and (in an exploratory subset) imaging and electrophysiological data as they transition toward
menopause. We hypothesize that baseline psychotic and cognitive symptom severity will predict conversion to
psychosis and that the worsening of these symptoms will correspond to specific clinical and hormonal markers
of the menopause transition. We also hypothesize that candidate psychosis biomarkers will predict conversion
and functional decline and will be impacted by markers of the menopause transition. Together, these studies
will be the first to identify definitive risk factors for psychosis development in aging women. Our goal is to use
the data generated to develop specific interventions to mitigate risk for psychosis in this vulnerable population.

Public health relevance
PROJECT NARRATIVE Women are at elevated risk of developing psychosis during the menopause transition, but the clinical, demographic, and neural factors predisposing to that risk remain poorly understood. Prediction of risk for developing psychosis earlier in life has benefitted from the systematic study of the time period just preceding the onset of frank psychosis–the psychosis prodrome. We propose to study the prodrome both retrospectively and prospectively in women during the menopausal transition, with the goal of identifying specific risk factors for development of psychosis during this high-risk period.